Evaluating Antigen Spread After cDC1 Vaccination

PROJECT SUMMARY
Type 1 conventional dendritic cell (cDC1) vaccination is a novel pre-clinical cell therapy that elicits systemic
immunity in several murine tumor models, including melanoma, and augments response to immune checkpoint
blockade (ICB). cDC1s possess the ability to cross-present tumor antigen to CD8+ T cells, migrate from tumors
to tumor-draining lymph nodes, and enhance naïve CD8+ T cell priming; however, mechanisms by which cDC1s
elicit effective anti-tumor CD8+ T cell responses in the context of vaccination remain unclear. My project will
explore the potential of cDC1 vaccination alone and in combination with αCTLA4 ICB to generate diverse and
effective CD8+ T cell responses. Specifically, I will study the ability of cDC1s to induce antigen spread, which is
defined as induction and expansion of T cell clones that were not a direct target of or present in the initial targeted
therapy. Importantly, antigen spread has been observed in patients responsive to immunotherapy and may
present an opportunity to counteract tumor antigen loss that can occur during tumor evolution. It is thought to
occur after tumor antigens, released from dying tumor cells, are phagocytosed by antigen presenting cells
(APCs) and cross-presented to naïve T cells to stimulate their activation. In addition, CTLA4 blockade can induce
antigen spread by promoting T cell costimulation and lowering the activation threshold for naïve T cells during
priming. The specialized functions of cDC1s create an ideal setting to study antigen spread. My project
investigates the ability of a target-antigen-loaded cDC1 vaccine alone and with αCTLA4 to control target antigen-
expressing (antigen-positive) and target antigen non-expressing (antigen-negative) tumors using B16F10 and
YUMM1.7 murine melanoma lines expressing ovalbumin (B16F10) and mLama4 and mItgb1 (YUMM1.7) as
target antigens. I hypothesize that cDC1 vaccination elicits antigen spread, and that combination treatment with
cDC1 vaccination and αCTLA4 further potentiates tumor control through increasing CD8+ T cell diversity. In AIM
1, I will test the hypothesis that the target antigen-loaded cDC1 vaccine will control target antigen-positive and
target antigen-negative tumors, and that cDC1s enhance αCTLA4 efficacy against target antigen-negative
tumors by enhancing the quantity and quality of the CD8+ T cell response. In AIM 2, I will test the hypothesis
that cDC1 vaccination with αCTLA4 will result in the most diverse CD8+ effector T cell repertoire, and that cDC1
vaccination elicits a CD8+ T cell transcriptional state that promotes tumor control. The Watowich and Yee
laboratories at MD Anderson provide the ideal environment to conduct my proposed studies, as I will learn
cutting-edge immunotherapy techniques, strengthen my fundamental immunology knowledge, and acquire
pertinent bioinformatics analysis skills under the direct guidance of my mentors. This training environment will
afford me the chance to learn from world leaders in tumor immunology and grant access to state-of-the-art
facilities and resources that are integral to my further development of my career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE There remains an unmet need to develop nontoxic cell therapies for patients with cancer that can elicit sustained and effective immune responses, and an unmet need to improve response rates for existing therapies. The proposed research will explore the use of a novel pre-clinical cell therapy using type 1 conventional dendritic cells (cDC1s) to promote diverse anti-tumor CD8+ T cell responses and further improve response to immune checkpoint blockade.